A Pilot Feasibility HIV prevention Study Linking Incarcerated Women to Post-Release Pre-exposure prophylaxis (PrEP) Services

ABSTRACT
This application proposes to adapt a Formerly Incarcerated Transitions (FIT) program for mostly African
American women, often with health disparities, who are released from incarceration and at high risk for HIV
acquisition. We propose to refer eligible incarcerated women for HIV pre-exposure prophylaxis (PrEP), a highly
effective biomedical prevention strategy. Our novel HIV prevention program, FIT for PrEP (F4P), will leverage
the infrastructure of a successful FIT program, revise and adapt it to link these at-risk women post- release to
PrEP services with adjunctive social services. Guided by the 5-steps of the Centers for Disease Control and
Prevention’s ADAPT framework (Assess, Select, Prepare, Pilot, Implement), F4P is modified specifically to
address the individual and structural barriers that women face during community re-entry preventing post-
release PrEP use. Previously, we completed steps 1 (Assess the target population’s needs) and 2 (Select the
intervention to adapt). This application targets step 3 (Prepare) by pre-testing and refining the intervention
to address the needs of the target population, and step 4 (Pilot) by testing the adapted intervention. We propose
to refine our novel F4P program, which increases access to HIV PrEP to women experiencing incarceration
(WEI). Peer Community Health Workers (CHW) with incarceration histories will begin meeting with WEI before
their release to provide PrEP education, needed social support, serve as role models, and link WEI to post-
release health care including PrEP. CHW will also address WEI’s social determinants of health during the
community re-entry period. We will refine our novel F4P program based upon feedback from WEI, CHWs, and
FIT clinicians using iterative Plan-Do-Study-Act (PDSA) cycles. We plan to randomize sixty WEI
to either the F4P program or Stay Healthy cardiovascular prevention (attention) control arm and use quantitative
and qualitative approaches to assess the acceptability and feasibility of the F4P program. To gain preliminary
evidence for efficacy, PrEP initiation will be compared between the two groups at week 12 in aim 3. In
addition, the other PrEP care continuum steps will be measured to inform the future efficacy trial. The PI and Co-
I’s are experienced and have long-standing collaborations conducting research and implementing programs
within the NC women’s prison, FIT programs and NC community health centers. This application is both
innovative and highly significant because F4P expands the current HIV correctional prevention paradigm to
biomedical prevention (PrEP). F4P builds on the successful FIT model to target WEI, a high- risk yet
understudied US population. It strives to reduce health disparities among a socially and economically
marginalized group of African American women. The resulting data on F4P’s acceptability, feasibility, and
preliminary effect will inform a R01 application to evaluate the intervention’s efficacy in increasing WEI’s post-
release PrEP adherence and retention in care.

Public health relevance
NARRATIVE Criminal justice-involved women, who are predominantly African American, are among the highest risk women in the U.S. to acquire HIV with few having access to effective HIV prevention medications called HIV pre- exposure prophylaxis or PrEP. Formerly incarcerated community health workers can link criminal justice involved women to community medical care by addressing re-entry barriers to care such as housing, unemployment, and lack of transportation. This study aims to improve the feasibility of an innovative criminal justice woman focused PrEP care linkage program utilizing the formerly incarcerated community health workforce.